Center for Studies of Host Response to Cancer Therapy

PROJECT SUMMARY/ABSTRACT
The objectives of the Center for Studies of Host Response to Cancer Therapy are to (1) form a self-sustaining
multidisciplinary research center within the University of Arkansas for Medical Sciences (UAMS) to increase the
understanding of mechanisms of side effects of cancer therapy, identify methods for early detection, and develop
strategies to prevent or treat such side effects and (2) help junior investigators with research programs in this
common theme establish themselves as independent scientists. Achieving these goals will create a vibrant,
multidisciplinary yet synergistic research environment. To our knowledge, few research centers focus on cancer
survivorship, and none take the paradigm-shifting approach of proactively addressing treatment-related toxicities
to improve overall cancer treatment outcomes. Specifically, this Center will provide an environment for young
investigators to succeed as independent scientists (Aim 1); strengthen the overall research infrastructure at
UAMS and the Winthrop P. Rockefeller Cancer Institute (Aim 2); and ensure that the Center becomes self-
sustaining (Aim 3). All 6 project leaders recruited to the Center in Phase 1 have built well-funded, productive
research programs and close collaborations with each other and several of the pilot project grantees. In
preparation for Phase 2, we have recruited 4 promising new/early-stage independent investigators. During Phase
1, the Center focused heavily on radiation therapy. To increase the impact and scope of the Center while
retaining its overall theme, project leaders recruited for Phase 2 have a research focus on both radiation and
chemotherapy. To increase the likelihood that project leaders will successfully secure independent extramural
research funding, individualized mentoring and faculty-development plans will be implemented, and support from
an administrative core and 2 research service cores will be integral. To replace project leaders who achieve
independence and graduate from COBRE support, a pipeline of new project leaders is ensured through
institutional support for recruiting junior faculty combined with a structured pilot project program. Strengthening
our interactions with the 5 other COBRE Centers and additional NIH-supported programs that enhance
biomedical research on the UAMS and affiliated campuses will also contribute to establishing the Center as a
self-sustaining research program that is well-integrated in the institution. The Center's progress will be guided
by highly qualified External and Internal Advisory Committees. Strong institutional support combined with active
interest from funding agencies in improving uncomplicated cancer cure rates and the quality of life of cancer
survivors ensures a high likelihood of success for the Center for Studies of Host Response to Cancer Therapy.

Public health relevance
PROJECT NARRATIVE Many cancer patients and survivors suffer from adverse effects of treatment that can present during and after the completion of cancer therapy. The COBRE Center for Studies of Host Response to Cancer Therapy brings together and supports investigators from various disciplines who perform research to understand mechanisms by which cancer therapy causes adverse effects; identify new methods for early detection of side effects; and develop novel strategies to reduce these side effects. The overall goal is to build a self-sustaining research center that aids in making cancer treatment safer and maximize the number of uncomplicated cancer cures.